Learning Health System Embedded Scientist Training and Research (LHS E-STaR) of theNorth (LEaRN)

PROJECT SUMMARY (Overall)
A lag between biomedical research discoveries and the implementation of findings in clinical care is widely
recognized and primarily attributed to a disconnect between researchers and practitioners. One study found
that over the course of 17 years, only 14% of clinical research findings led to direct patient benefit. A reason
research findings are often do not implemented in clinical practice is because health services research takes
place over extended timeframes and researchers place an emphasis on publishing their findings in scientific
journals with less attention to application. Moreover, most researchers are typically external to healthcare
systems, conducting their research in universities or research firms. Closing the gap in translating research
findings to clinical care requires a new way of conducting research by embedding researchers in health care
systems, allowing them to engage in rapid, iterative learning in which evidence informs practice, and practice
informs evidence. The vision of the proposed Learning Health System Embedded Scientist Training and
Research (LHS E-STaR) of the North (LEaRN) Center is to leverage and extend existing infrastructure and
partnerships established at the University of Minnesota (UMN) under the Minnesota Learning Health System
K12 Mentored Career Development Program (MN-LHS) and its Center for Learning Health System Sciences
(MN-CLHSS). The LEaRN Center will accelerate the professional development and patient-centered outcomes
and comparative effectiveness research (PCOR/CER) conducted by specially trained, embedded LHS
researchers in the Minnesota health care system and beyond. The LEaRN Center represents a partnership
between UMN and five hub partner sites with established traditions of academic excellence and collaboration
between clinicians and embedded scientists with demonstrated success achieving the long-term goal to
expand and diversify the LHS-research trained workforce. Led by MPIs Timothy Beebe and Genevieve
Melton-Meaux, the LEaRN Center will leverage the unique strengths of five hub partners to provide diverse
didactic and experiential research and training opportunities to LHS scientists to equip them with the LHS tools
and expertise to make meaningful differences in health care settings serving children, the elderly,
under-represented and rural populations, Veterans, and individuals with multiple disorders. The LEaRN Center
will address five Aims: leverage and expand existing LHS infrastructure and partnerships to identify and
nurture a new generation of embedded LHS scholars (Aim 1); enhance the diversity of LHS scientists, their
science and their mentors (Aim 2); create a novel LHS infrastructure that supports the conduct, dissemination,
implementation, and use of PCOR/CER in healthcare system (Aim 3); create learning communities and
networks to convene, deliberate, and share knowledge (Aim 4); and implement a rigorous system for program
evaluation and improvement (Aim 5). The LEaRN Center will cultivate the next generation of LHS scientists
with the expertise, field experience, and community and professional partnerships to close the gap between
researchers and clinicals and assume LHS leadership roles.

Public health relevance
Project narrative The purpose of the Learning Health System Embedded Scientist Training and Research (LHS E-STaR) of the North (LEaRN) Center is to create a dynamic training and research environment for scholars to learn in, and meaningfully improve, healthcare systems within and outside of Minnesota.